CRST COVID-19 - Wayakta He

Title: CRST COVID-19 Wayakta He? (Are you on guard against COVID?) PI: E. Erdei
Project Summary
Ongoing concurrent pandemics of Severe Acute Respiratory Syndrome Coronavirus 2 (SARS-CoV-2)
infections and toxic exposures originated from electronic cigarette (e-cig) and secondhand smoke had taken
devastating tolls on minority communities in the U.S. Rather than being “the great equalizer” due to universal
lack of immunity, evidence has shown that the burden of COVID-19 disease has been disproportionately felt by
racial/ethnic minority and low-income communities. This stark and most current health disparity is likely due to
a variety of psychosocial stressors stemming from structural inequalities that place individuals of color and/or
low socioeconomic status, including American Indian/Alaska Native communities at greater risk for the
contraction of SARS-CoV-2 infection and severity of COVID-19 disease. A recent literature showed that
overall COVID-19 diagnosis was associated with youth use of e-cigarettes. However, that study did not look
specifically at younger generation of American Indian and Alaskan Native (AI/AN), and how other factors within
tribal communities affect disease susceptibility. This proposal is submitted in response to "Mechanism for
Time-Sensitive Research Opportunities in Environmental Health Sciences ", RFA-ES-19-011. Aim 1 will
employ a community-based data collection of socioeconomic and environmental stressors in the Cheyenne
River Sioux Tribal (CRST) communities in South Dakota by administering a tribal-specific survey, which will
constitute the CRST SARS-CoV-2 infection prevalence collected in 300 participating CRST households with
600 distinct participants representing a wide-range of ages (18-89 yrs). The development of novel and time -
sensitive data during the ongoing CRSRT pandemic on social factors and environmental toxicants will expand
under Aim 2 by capturing detailed personal behaviors (i.e. vaping), stressors, Tribal housing, and by measuring
environmental health factors that may impact COVID-19 disease susceptibility, severity and immune response.
Detailed immunological assessment (total IgA, viral-specific IgG & IgM positivities and cortisol) will be carried
out by using non-invasive saliva sampling. These measures will help us to assess the association between risk
factors from Aim 1 survey data and RT-PCR confirmed SARS-CoV-2 viral infection prevalence. Based on
passive air monitoring we will be able to evaluate the association between airborne exposures to nitrogen
dioxide and airborne nicotine in the homes with increased susceptibility for SARS-CoV-2 infections and
increased viral-specific IgM and decreased protective IgG response. We will assist CRST COVID-19
Command Center by generating a community-driven, COVID-19 targeted, public health literacy, and by
capturing population-based infection susceptibility risks and specific immune response data. Our hypothesis is
that increased SARS-CoV-2 infections among CRST community members are associated with vaping and
indoor secondhand smoke, lower socioeconomic status, the type of heating sources used in homes, large
multigenerational households (>3.4 people in one home), and living in multi-unit Tribal housing complexes.

Public health relevance
Title: CRST COVID-19 Wayakta He? (Are you on guard against COVID?) PI: Erdei Tribal communities are hit hard by the current COVID-19 disease pandemic, why we lack of scientific evidence of what susceptibilities should be considered in assisting Tribes in future similar outbreaks and in designing preventive measures for affected communities. So far no appropriate attention has been paid to probable, contributing environmental contaminants and indoor factors extremely prevalent in these environmental justice communities. Our experienced Team by University of New Mexico Health Sciences Center PI, Johns Hopkins University and Missouri Breaks Industries Research Inc. Native American researchers would like to improve this situation in the Cheyenne River Sioux Tribal communities by finding out more about people's home and social environment by collecting time-sensitive biosamples and pollutant measures in the midst of the ongoing pandemic in CRST.